Examining ketamine effects on depression, neuroplasticity, and inflammation in Veterans with Parkinson's disease

Parkinson’s disease (PD) is a complex, disabling neuropsychiatric disorder with growing impact on Veterans in
terms of prevalence and disability. Depression in PD (dPD) is common, a stronger predictor of quality of life
than the hallmark motor symptoms of the illness, and associated with accelerated decline and elevated risk of
suicide. Unfortunately, current treatments have limited efficacy for dPD. This may stem from the widespread
brain degeneration in PD that likely contributes to the etiology and maintenance of depressive symptoms.
Thus, improving outcomes for the growing Veteran PD population requires developing new treatments that
address dPD’s complex pathophysiology. Evidence suggests that impaired neuroplasticity and elevated
inflammatory activity may be high-yield targets for novel antidepressants. Impairment in long-term potentiation
(LTP), a basic mechanism of neuroplasticity that depends on glutamatergic signaling at the N-methyl-D-
Aspartate receptor (NMDAR), has been specifically implicated in depression. Abnormal glutamatergic signaling
is a significant contributor to disease progression in PD: overactive glutamatergic transmission and excessive
NMDAR activation impair LTP in animal models and diminished “LTP-like” plasticity is found in PD patients.
Dysregulated inflammation, known to play a central role in PD pathophysiology, is linked to these
neuroplasticity deficits. The immune system is hypothesized to drive PD progression through
“immunoexcitotoxicity”, wherein inflammation up-regulates glutamate levels and the NMDAR; this
glutamatergic overstimulation impairs synaptic plasticity and induces cell death. Ketamine, an NMDAR
antagonist and robust antidepressant, may offer a promising new approach to treating dPD. Ketamine not only
reduces depressive symptoms, but also has neuroplasticity-enhancing and anti-inflammatory effects that have
been observed in both preclinical and clinical studies. Recent preclinical work also suggests that ketamine can
improve mood and offer neuroprotection in PD. Thus, ketamine may have the potential to reduce depression in
PD while also targeting key components of PD pathophysiology, thereby having disease-modifying effects. To
date, no published studies have examined the effects of ketamine in humans with PD. To address this gap, we
propose a randomized, placebo-controlled study evaluating the effects of a single infusion of ketamine versus
placebo (remimazolam) in Veterans with dPD (N=80). We hypothesize that ketamine will have a strong safety
and tolerability profile and improve depressive symptoms within 24 hours (Aim 1). Further, its antidepressant
effects will be associated with modulation of both impaired neuroplasticity (Aim 2) and elevated inflammatory
activity (Aim 3). To test these hypotheses, we will use clinical assessments (of adverse events, Veteran-
reported tolerability, and depression), non-invasive brain stimulation techniques to quantify changes in LTP-like
neuroplasticity, and blood-based cytokine measurement to quantify changes in systemic inflammation. The
proposed study will provide clinical efficacy data and elucidate ketamine’s mechanisms of action in PD using
accessible, neuroscience-informed markers of neuroplasticity and inflammation. Findings will lay the
groundwork for a multi-site Merit-funded trial. The study is well-aligned with VA priorities to promote cross-
disciplinary efforts by psychiatry and neurology to improve outcomes for Veterans with PD. The training plan
will allow the candidate to develop new skills in: (1) design and conduct of clinical pharmacologic trials focused
on the Veteran PD population; (2) using transcranial magnetic stimulation (TMS) to efficiently assess
neuroplasticity; and (3) using peripheral cytokine assays to assess systemic inflammatory activity. Training will
also expand the candidate’s knowledge of high-yield scientific areas including PD pathophysiology, the role of
impaired neuroplasticity in neuropsychiatric illness, and psychoneuroimmunology. This CDA-2 program will
allow the candidate to launch a career as a VA physician-scientist focused on accelerating the development of
new pharmacologic treatments for serious neuropsychiatric disorders through mechanistic clinical trials.

Public health relevance
Parkinson’s disease (PD) is a devastating illness that has a growing impact on Veterans. One of the most disabling symptoms is depression, which is common in PD and linked to poor quality of life and higher risk of suicide. Unfortunately, we lack effective treatments for depression in PD. Ketamine, which has rapid and potent antidepressant effects, is a potential option but has not been tested in Veterans with PD. Studies in rodents show that ketamine may not only improve depression in PD, it may target two of the underlying drivers of the disease: (1) reduced neuroplasticity, or the brain’s ability to adapt and remodel itself; and (1) elevated inflammation. We propose a randomized, placebo-controlled study to examine if a dose of intravenous (IV) ketamine improves depression in Veterans with PD. We will also examine ketamine’s effects on neuroplasticity and inflammation, which will help us understand how ketamine works in PD and if it can be a useful treatment for Veterans with the disease. This study will lay groundwork for a larger clinical trial across multiple VA sites.